Planning and Evaluation Core

PROJECT SUMMARY
Planning and Evaluation Core
The overall goal of Planning and Evaluation Core (PEC) is to build on the infrastructure created and continue to: 1) improve the foundation to support planning, monitoring and evaluation of the impact of research projects, cores and shared resources of Temple University Fox Chase Cancer Center (TUFCCC) and Hunter College (HC) Partnership on reducing cancer health burden; and 2) maximize resources, identify new directions and actively facilitate by bringing senior faculty, early-stage investigators, and trainees together to design and pursue cutting-edge cancer research through rigorous solicitation, evaluation, and selection of new projects, using NIH grant review criteria. Guided by the TUFCCC/HC Partnership Logic Model, the PEC team will collaborate with each Core/Project leaders to develop specific evaluation plans; implement procedures to collect all necessary evaluation data with the least cost and burden to Partnership leaders, researchers, and community members. The PEC team will introduce new features to enhance our capacity for evaluating the scientific integration and collaboration across the Partnership, bi-directional community engagement, and institutional changes, both qualitatively and quantitatively. The PEC will leverage the innovative Comprehensive and Dynamic e-Platform (CDEP) established during current TUFCCC/HC Partnership 1.0 to further strengthen the support for planning, process, outcome, and impact evaluation of all Core/Projects and the overall Partnership. Building on the robust process, the PEC team with support of the AC, IAC, PSC and NCI will solicit, evaluate, and select new research projects to increase the competitive research capacity among TUFCCC/HC partners and promote cutting-edge basic, clinical, translational, and community-based research initiatives in cancer care for communities in our institutional catchment areas. The PEC will use the NCI Grid-Enabled Measures (GEM) Platform to organize and facilitate consensus building within and across the Partnership in shared program priorities, shared common metrics, measures, benchmarks, analysis, and dissemination. Broadly, this evaluation will include a three-tier strategy, focused on individual Cores/Projects, the overall Partnership, and the broader collaboration between the TUFCCC/HC Partnership, and communities served by other NCI/CRCHD funded Partnerships. The PEC renewal application is designed to identify resources and improve infrastructure in Four Pillars: research projects, training/mentorship, and community outreach/engagement, as well as research capacity building. The PEC will be guided by the Partnership’s Vision to monitor progress and evaluate impact of U54 components and the overall Partnership towards advancing cancer health outcomes in the PNN region and beyond.